REGULATION OF GENE EXPRESSION IN MUCOLIPIDOSIS-II ZEBRAFISH

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are collaborating with the Steet lab to investigate changes in transcripts involved in extracellular matrix homeostasis in wild-type and ML-II zebrafish models.